Core--Agriculture and Botany Facility

DESCRIPTION: The aims of the core are to (1) identify and characterize species which are the source of dietary supplements using classical and molecular systematics, (2) determine genetic and cultivation factors that influence the levels of biological compounds thought to be responsible for positive health effects, (3) develop a molecular systematics classification for botanicals, and (4) provide information about botanicals to standardize the phytochemical levels in the plant products. The core uses the resources and facilities of two quality institutions, UCLA and Cal Poly Pomona. UCLA plant molecular biology group will develop the DNA-based taxonomy program and Cal Poly Pomona's School of Agriculture will conduct germplasm and cultivation studies. Cal Poly Pomona will conduct two projects the first will identify the best methods for germination, transplantation, and cultivation of botanicals for commercial use and will examine the best ways for the storage of germplasm (including dormancy requirements) for future cultivation needs. The UCLA facilities will do DNA fingerprinting of botanicals to try to determine the tags or markers associated with specific bioactive components of concern.